The Einstein-Montefiore Diversity, Equity, Inclusion, and Accessibility (DEIA) Mentorship program

ABSTRACT
This is a proposal for a supplement to the R01 entitled Understanding cellular and transcriptional regulatory
changes in human aging. It responds to NOT-OD-22-057, the Notice of Special Interest (NOSI): Administrative
Supplements to Recognize Excellence in Diversity, Equity, Inclusion, and Accessibility (DEIA) Mentorship.
The parent R01 studies the ‘epigenetic’ events involved with ageing in humans, extending beyond the typical
consideration of cellular reprogramming events into systematic cell subtype proportional changes, and the
unmasking of functional DNA sequence variants with age.
As this project permits the development of techniques that permit insights into DNA sequence variants in non-
coding regions that can influence the risk of disease in people of diverse genetic ancestry, represented strongly
by our community here in the Bronx, the project has attracted individuals from diverse, under-represented
groups, with diversity supplements awarded to an indigenous postdoctoral fellow and a Hispanic graduate
student.
While such funding is individually very valuable, it has become apparent that there needs to be a more general
institutional climate in place to foster the careers of those from typically excluded groups. The NOSI described
above provides the opportunity to fund an institution-wide program to enhance the careers of these under-
represented colleagues.
We describe an intensive one-year plan to develop and implement a new curriculum towards this goal. We will
leverage existing institutional resources, develop new programs, and harness external consulting resources in a
new, integrated course.
We will protect the time of program participants and faculty, and will collect information systematically about the
program so that we will, at the end of the year, have collected enough data to direct how ongoing resource
investment should be targeted.
Our goal is to guide our institution’s development of an equitable environment that provides very active training
for those from minoritized groups, developing the future leaders who will amplify the benefits of the training to
an increasingly large part of our academic community.

Public health relevance
NARRATIVE This proposal represents a supplement to an existing project that currently supports two trainees from diverse backgrounds. While valuable, funding that targets individuals does not permit more systemic change within an institution. Here we propose to perform a one-year, intensive mentorship program to develop future leaders from minoritized groups, working with colleagues throughout this institution to test the effectiveness of these interventions, and establishing a foundation for a long-term program to enhance the training and opportunities of diverse colleagues in our medical school.